Scalable Biomarkers and Generative Digital Twins for Personalized Neurostimulation in Depression

Project Summary/Abstract
More than 100 million people in the United States currently show signs of clinical depression, approximately
three times more than before the onset of the COVID-19 crisis. Currently, the main treatment options for such
depressed individuals include pharmacological and psychological interventions, the acute and long-term
effectiveness of which are significantly limited: up to one-third of patients develop treatment-resistant
depression. Noninvasive neurostimulation therapies such as repetitive Transcranial Magnetic Stimulation
(rTMS)–where a magnetic coil placed over the cortex is used to focally stimulate the brain–have recently
emerged as promising low-risk interventions for treatment-resistant depression. However, the mechanisms and
appropriate parameters for this treatment remain poorly understood. In the best cases, rTMS can have
dramatic effects, changing the course of a patient's life in hours. In many cases, however, it has little to no
measurable effect. This raises the obvious question: why do current rTMS protocols work well for some
individuals but not for others? Could we adapt protocols to work well for everyone, potentially providing reliable
personalized treatment or even a lasting cure? A growing literature suggests this is possible if we learn to tailor
treatment to individual differences in human neurophysiology. Here we propose an innovative and unique
approach towards precision psychiatric neurostimulation: personalized modeling of treatment using
“Generative Digital Twins”. To affordably build and scale Generative Digital Twins, we propose combining high
density electroencephalography (HD-EEG)–which is non-invasive, inexpensive, and easily deployable–to
measure longitudinal changes in brain connectivity during an accelerated rTMS treatment protocol for
depression. Then, using controllable generative neural networks that allow detailed predictive simulations of
individual response trajectories given rTMS treatment, we can begin to predict outcomes prior to treatment,
understand individual responses, and personalize treatment parameters.

Public health relevance
Project Narrative Depression is the leading cause of disability worldwide with a lifetime prevalence of ~17% in the United States, with one third of cases developing treatment-resistant depression. Noninvasive neurostimulation therapies such as repetitive Transcranial Magnetic Stimulation (rTMS)–where a magnetic coil placed over the cortex is used to focally stimulate the brain–have recently emerged as promising low-risk interventions for treatment-resistant depression, but it is unclear why they work incredibly well for some patients and not at all for others. We propose a bold new approach to personalization of rTMS treatment that uses generative neural networks to learn and then simulate possible treatment response trajectories for depressed patients in order to improve personalization and better understand the mechanisms of accelerated neurostimulation treatments.